Genome-wide sieve analysis and immunological validation to identify targets of protective efficacy in field trials of a whole-organism malaria vaccine

Abstract
PfSPZ Vaccine, a radiation-attenuated, whole-organism vaccine against P. falciparum (Pf) malaria, based on
the Pf NF54 strain, has consistently shown durable, high (>85%) protective efficacy against a homologous
parasite strain after controlled human malaria infection (CHMI). This result represents a major milestone in the
fight against a disease that kills >400,000 people annually. At current dosages, PfSPZ Vaccine has been
shown to have significant but still incomplete protective efficacy against naturally acquired malaria infection, as
well as against CHMI with a heterologous strain. The most expedited, informed path to broaden the efficacy of
this vaccine relies on the knowledge of the parasite proteins against which the immune system mounts a
protective response following immunization with PfSPZ Vaccine. Here, we propose to use parasites,
specimen samples and clinical outcomes from the three largest efficacy field trials of PfSPZ Vaccine,
to identify and validate parasite protein targets of the vaccine-induced protective immune response.
We will generate whole genome sequence (WGS) data from ~400 Pf infections from controls and vaccinees in
three field efficacy trials conducted, under separate funding, in Kenya, East Africa, and in Gabon, Central
Africa. In AIM 1 we will develop new Pf genome reference assemblies from recently collected strains for East
and West Africa, to increase the quality and quantity of sequence variants (SNPs and indels) identified in these
clinical samples. In AIM 2, we will use the genome-wide genotype calls in these 400 samples to compare
infections in vaccinees vs. controls, in order to identify parasite antigens targeted by PfSPZ Vaccine-induced
protective immunity (“target loci”), under the assumption that, in these target loci, allele frequency distributions
will differ in malaria infections in the vaccine vs. control arms of field efficacy trials, including a lower frequency
of NF54-like alleles in vaccinees than in controls. We will use similar samples from control and vaccine arms of
a new PfSPZ Vaccine field trial, to start in Equatorial Guinea in 2018, to validate these results. Finally, in AIM
3, we will conduct a high-throughput immunologic validation of Pf targets of PfSPZ Vaccine-induced protection
that will determine whether or not allele-specific efficacy is indeed a phenomenon that impacts whole
organism-based vaccines. These results will be used to inform the choice of additional P. falciparum strains
with which to design multivalent vaccines with broader efficacy, and hopefully lead to a decrease in disease
burden and improve the prospects of malaria eradication. By defining the targets of the immune response to a
malaria parasite, this research may also expand our understanding of host immune responses to whole-
organism vaccines against parasitic diseases, and accelerate future developments in this field.

Public health relevance
Project Narrative The whole organism-based PfSPZ Vaccine against malaria is highly protective against homologous challenge but shows incomplete protection against heterologous challenge and against diverse parasites in field trials, suggestive of strain-specific efficacy. We propose to apply comparative population genomics approaches to parasite whole genome sequence data, which we will generate from the vaccine and control arms of field trials of PfSPZ Vaccine, to identify parasite antigens targeted by the protective immune response induced by the vaccine. We propose to validate allele-specific efficacy of the vaccine, and candidate antigens it targets, by using a “diversity-encompassing”, ultra-dense peptide array populated with all antigen variants identified in the study, and probed with sera from participants in one of the PfSPZ Vaccine trials.